Mitochondrial Fidelity and Homeostasis

PROJECT SUMMARY/ABSTRACT
Mitochondria are complex, dynamic organelles that are essential in virtually all eukaryotes. They play important
roles in various vital processes including energy conversion, synthesis of iron-containing cofactors and
metabolic intermediates, immune signaling, and cell fate choices. Although knowledge about mitochondrial
biology is increasing, the mechanistic understanding of how mitochondrial functions are established,
maintained, and adjusted in response to physiological and stress cues remains incomplete. This is significant
as said mechanisms are highly relevant to both normal cellular physiology and a wide range of Mendelian and
common age-related human disorders – including glaucoma, hearing loss, Parkinsonism, amyotrophic lateral
sclerosis, various neuropathies, dementia, and certain cancers – for which no effective therapies currently
exist. The overarching goal of this research program is to determine how evolutionary conserved mitochondrial
quality control modules function to maintain cell survival and how these functions can be manipulated to
achieve clinical benefits. Unified by the topic of mitochondrial fidelity and protein homeostasis, the program
utilizes multidisciplinary approaches to address key gaps in knowledge about conserved mechanisms through
which compartmentalized protein folding, stability, assembly, and membrane integrity are safeguarded to
ensure proper mitochondrial functions. The proposed studies focus on the following directions: 1)
Understanding disease-relevant mechanisms that govern proteolytic and proteostatic control at the inner
mitochondrial membrane; and 2) Elucidating how a delicate protein homeostasis in the mitochondrial matrix is
established and maintained. In each direction, the proposed work will focus on a group of dedicated factors
that mediate protein, ion, and metabolic homeostasis in mitochondrial subcompartments, thereby ensuring the
organelle's self-preservation under basal and stress conditions. Capitalizing on previous findings and novel
tools and approaches developed by the PI and colleagues, the team will identify and characterize the
mechanisms behind these processes. Expected outcomes will deepen the fundamental understanding of
mitochondrial biology and related pathogenic mechanisms of human diseases stemming from progressive
mitochondrial dysfunction due to quality control of failing organelles.

Public health relevance
PROJECT NARRATIVE Progressive dysfunction of mitochondria – organelles that are central to cellular physiology and metabolism – is associated with several prevalent human diseases, such as neuromuscular and psychiatric disorders, heart disease, certain cancers, and aging-related neurodegeneration. Yet, despite their critical biological importance, the mechanisms that ensure mitochondrial fidelity and adjust mitochondrial functions in response to physiological and stress cues is limited. This program will advance knowledge of these processes, ultimately enabling new therapeutic targets to treat oncological, age-related, and other forms of disease.